COMPARATIVE STUDY ON GLOMERULAR HEMODYNAMICS BETWEEN BLACK AND WHITE

The purpose of this study is to determine whether patients with high blood pressure have altered blood pressures in the small, filtering blood vessels of their kidneys.